The MYC Transcription Factor Network and the Path to Cancer

Myc proteins are essential for normal cellular growth and proliferation. However, when its normal regulation
is compromised (i.e. deregulated) Myc promotes initiation and progression of a broad spectrum of human
cancers. Myc has been long known to be a transcription factor that heterodimerizes with the Max protein in
order to specifically recognize DNA. When deregulated, Myc-Max alters gene expression programs resulting
in metabolic and growth related changes that in turn support tumor progression. Recent studies show Myc-
Max does not function alone, but is part of a larger transcriptional “network” of related, yet functionally dis-
tinct, factors that heterodimerize with either Max or the Max-like protein MLX, or both. In order to understand
and control Myc's role in the etiology of cancer it will be essential to define how Myc both depends on and
influences the extended network. This application builds on 3 broad aspects of our ongoing studies:
Transcriptional reprogramming of metabolism: We had earlier uncovered a critical role for Mlx, and its hetero-
dimeric partner MondoA, in the metabolism and survival of several Myc-driven tumors. Focusing on pancre-
atic adenocarcinoma we will examine cross-talk and functional dependencies involving Myc in the context of
its extended network that may be exploited to identify new therapeutic strategies. Moreover, Myc and the
other network proteins are transcription factors and we will determine their shared target genes and their co-
operative effects on chromatin modifications and higher order structure as well as gene expression.
Tumor suppression mediated by Mga, a member of the Myc Network: Mga is a large and unusual transcrip-
tion factor with two distinct DNA binding domains, one of which dimerizes with Max, binds DNA, and is fre-
quently subject to deletion or mutation in a wide range of neoplasms. However, little is known about Mga's
oncogenic functions. Our very recent findings that Mga loss of function results in altered cell motility in vitro,
and rapid lung adenocarcinoma formation in mice provide a biological system to elucidate Mga's capacity to
suppress cancer. We will define regions in Mga essential for DNA binding, identify transcriptional complexes
associated with Mga, and assess how loss of Mga leads to tumor initiation, progression and metastasis.
Molecular alterations driving Myc oncogenicity: we introduced a point mutation (T58A), associated with B cell
lymphomas and AML, within the phosphodegron of the endogenous murine myc gene. In these mice, Myc-
T58A is regulated normally with no overt changes in tissue growth or proliferation. Yet we find that myc-T58A
mice display increased hematopoietic progenitor cell self-renewal and resistance to apoptosis, and develop
long-latency AML or lymphoma. Our data show that the Myc-T58A mutation alters the association of Myc
with a specific co-regulatory complex. We hypothesize that this altered binding modifies expression of a sub-
population of Myc target genes during hematopoiesis, resulting in production of tumor initiating cells. We plan
to elucidate the underlying molecular basis for the T58A phenotype in these tumor-prone mice.

Public health relevance
The Myc protein is an essential regulator of growth in all normal cells, but in many cancers Myc is escapes normal controls and supports high rates of growth needed for tumor progression. In this proposal we will determine what events contribute to activation of Myc in tumors and devise approaches to inhibit Myc function. This research is relevant to public health because it will ultimately lead a better understanding of the causes for cancer and provide new approaches to cancer therapy.